Structure and function of glycolytic enzymes and their cellular regulation

PROJECT SUMMARY
Glucose metabolism plays a crucial role in cellular homeostasis and is central to diseases like cancer,
diabetes, and neurodegenerative disorders. Despite extensive biochemical and enzymological
characterization, the cell biology of many metabolic enzymes remains poorly understood. Targeting glycolytic
enzymes in diseases in which they are dysregulated, such as cancer, diabetes, and inflammation, is a currently
proposed therapeutic strategy. However, this strategy requires understanding how glycolytic enzymes are
regulated in time and space, a process that remains unresolved. Phosphofructokinase-1 (PFK1), a key
regulatory enzyme of glycolysis, is controlled through complex mechanisms, but its spatial and temporal
dynamics in cells and role in disease-related metabolic reprogramming remain unclear. This proposal will
determine the regulation of PFK1 in vitro and in cells. Specifically, we will examine the how the liver isoform of
PFK1 assembles into filaments and how this regulates glucose metabolism in hepatocytes and how a glycolytic
metabolon regulates the migration of breast cancer cells. We will also determine how the carboxy terminal tail
domain of PFK1 stabilizes the inactive conformation and how its inhibitory effects are relieved in response to
metabolic and hormonal signaling. By employing high-resolution structural analyses, cellular assays, and
innovative molecular tools, the project seeks to provide a comprehensive understanding of the spatial and
temporal regulation of PFKL. Our findings will advance the field of cell metabolism and cell biology, will provide
insights into their dysregulation in disease, and may aid in the development of novel therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Cells use sugar to generate energy and building blocks but we don’t fully understand how the cellular machinery that breaks down sugar work. Broken and improperly regulated sugar processing machinery has been linked to diseases such as cancer, diabetes, and inflammation. We propose to study ways that one of these machines is regulated, which could lead to new ways to treat disease.